QUANTUM CHEMISTRY STUDIES OF PROTEIN BACTERIORHODOPSIN

The quantum chemistry packages Gaussian92/94 [54] were employed to study the electronic excitations [55, 56] and the darkadaptation potential surfaces [55, 57] of in situ retinal. CASSCF(8,8)/6- 31G level ab initio calculations were carried out with the protein environment represented through explicit point charges in theelectronic Hamiltonian of retinal. The calculations were appliedto an ensemble of bacteriorhodopsins generated by molecular dynamics simulations using a CHARMM force field with specialparameters for retinal torsions. Our approach resulted in a spectrum of bacteriorhodopsin, with a maximum at 530 nm, a width of100 nm for the native pigment and a spectrum shifted by 60 nmfor the D85N mutant.The calculated rate of dark adaptationat room temperature (~ 10-5s-1) and its enhancement throughAsp-85 protonation are in agreement with observation [58]. The excited state potential surface governing the photoreaction ofbacteriorhodopsin was determined for a protonated retinal Schiffbase analogue containing four double bonds using the quantumchemistry package MOLPRO95 [59, 60]. The calculations confirm that rotation around the 13-14 bond is the predominant photoisomerization pathway.It was found that for retinal geometriesclose to planar there exists a strong interaction between the firstand the second excited states, resulting in an avoided crossing between these two terms.On the other hand, a conical intersection between the first excited and the ground state, occurringat a 90o twist of retinal around the 13-14 bond, was detected.These results show that accounting for all three electronic terms (the ground, the first excited, and the second excited states) is ofcrucial importance for the proper description of the retinal photodynamics.